Diversity Supplement: A Just-In-Time Adaptive Mobile Application Intervention To Reduce Sodium Intake And Blood Pressure In Hypertensive Patients

PROJECT SUMMARY
High sodium intake is a significant public health problem associated with hypertension, which is
associated with a greater risk of stroke, cardiovascular risk and death. Despite guidelines
recommending less than 2,300 mg of sodium per day, the average sodium intake for the US
population is approximately 3,400 mg per day. Interventions that lower sodium intake can
decrease blood pressure and improve cardiovascular outcomes. The LowSalt4Life mobile
health (mHealth) application provides a just-in-time adaptive intervention (JITAI) to lower
sodium intake. This diversity supplement will support the research Aims and long-term career
goals of an outstanding, early career scientist at the University of Michigan (Cornelius A. James,
MD). Dr. James’ contributions to this study will make the findings more meaningful because they
will provide insight into how to implement and operationalize an intervention with demonstrated
efficacy. Specifically, Dr. James will conduct the following study entitled, “Clinician and Patient
Attitudes toward a Prescribed Dietary Sodium Just-In-Time Adaptive Intervention: A
Mixed Methods Study.” This supplement will seek to understand the attitudes of clinicians, and
patients related to use of a low sodium dietary JITAI. This understanding may not only inform
approaches to the improvement, development and implementation of the low sodium diet
dietary JITAI, and other mHealth applications, but it will also support a promising early career
scientist’s development.

Public health relevance
PROJECT NARRATIVE Mobile health (mHealth) applications have been shown to improve outcomes across a range of disease states. However, the attitudes associated with clinician prescribing, and patient use of mHealth applications are poorly understood. This project will look closely at the attitudes associated with clinician prescription and patient use of a dietary sodium JITAI intended to decrease sodium intake, lower blood pressure and improve cardiovascular outcomes.